Reconstitution and biophysical study of chromosome segregation machinery

Project summary
During cell division, duplicated chromosomes are segregated by an exquisite molecular machine, the mitotic
spindle. Our goal is to uncover how this machine operates by reconstituting spindle activities and applying
advanced biophysical tools for manipulating and tracking individual molecules. We focus on the components
most central to spindle function, kinetochores, microtubules, and spindle poles. Kinetochores drive
chromosome movements by maintaining persistent, load-bearing attachments to microtubule tips, even as the
tips assemble and disassemble under their grip. Kinetochores also somehow sense when they are
erroneously attached and, if so, they detach and generate diffusible ‘wait’ signals to delay anaphase until
proper attachments are made. Spindle microtubules are organized into a bipolar configuration by the spindle
poles, which also must sustain forces to support chromosome movements and spindle assembly. In past
work, we have developed motility assays where native kinetochores or recombinant kinetochore subcomplexes
are attached to individual dynamic microtubules. Like kinetochores in vivo, the isolated kinetochore particles
remain tip-bound even as the microtubule tips assemble and disassemble – a behavior we call ‘tip-coupling’.
We have also reconstituted attachments between microtubules and spindle pole bodies, the yeast counterparts
of centrosomes, and made the first measurements of their mechanical strength. Altogether our reconstitutions
have enabled us to make key discoveries in major areas of spindle function. By expanding our approach, we
can now attack the essence of many complex, long-standing problems in mitosis, in direct ways that would be
impossible in living cells. Over the next five years, we will focus on several important questions: (1) How do
kinetochores spontaneously self-assemble from their component parts? (2) How are forces transmitted from
the outer microtubule-binding interface through the middle of the kinetochore and ultimately to the centromeric
DNA? (3) How are dynamic behaviors at kinetochores and spindle poles affected by the forces they
experience? (4) How do kinetochores avoid making erroneous attachments? (5) How do unattached or
erroneously attached kinetochores generate ‘wait’ signals to delay the cell cycle? Our work will continue to use
the advanced, feedback-controlled laser traps that we pioneered for measuring kinetochore movement and
spindle pole mechanics. In addition, newly developed fluorescence techniques will allow us to observe
kinetochore assembly at the single molecule level and to monitor dynamic structural changes within individual
kinetochores. By combining laser trapping with fluorescence we will test directly how changes in the
composition and architecture of kinetochores and spindle poles affect their function.

Public health relevance
Project narrative During cell division, duplicated chromosomes are organized and separated by an exquisite molecular machine, the mitotic spindle. This project will bring us closer to a complete understanding of how the spindle works. Understanding the mitotic spindle is critical for developing better chemotherapeutics. Drugs that target tubulin are used against many cancers, but they cause considerable side effects. Unlike tubulin, however, other spindle components function only in dividing cells, so new drugs targeting these components could stop cancer proliferation with fewer side effects. In addition to its medical relevance, the work will bring us closer to a complete understanding of one of nature’s most fascinating molecular machines.